Single-Neuron Marking in the Study of Abnormal Cochleas

Summary - Abstract
Recent work in our laboratories has shown, in both noise-induced and age-related hearing
loss, that the most vulnerable elements in the inner ear are synaptic connections between hair
cells and cochlear neurons, and that this synaptopathy can be widespread (> 50%) even in
cochlear regions with no hair cell loss. Although this primary neural degeneration has little effect
on auditory/cochlear thresholds (thus, a “hidden hearing loss”), partial de-afferentation of
surviving inner hair cells is likely a major cause of difficulties understanding speech in a noisy
environment and may be a key elicitor of tinnitus. Synaptic loss silences the affected neurons,
absent a cochlear implant, however the slow death of the cell bodies and central projections
offers a long therapeutic window. Indeed, we have recently shown that neurotrophin-based
therapies can elicit synaptogenesis and partial functional recovery even in the adult ear.
Here, we extend our prior work on cochlear synaptopathy in both basic-science and
translational directions via four closely coupled Aims in our mouse model of noise-induced
synaptopathy. Aim 1 is a neurophysiological and intracellular labeling study of single auditory
nerve fibers (ANFs) testing the hypothesis that, by eliminating ANFs with high thresholds and
low spontaneous rates (SRs), synaptopathy compromises stimulus coding in the presence of
background noise. We also use the single-unit data to optimize a diagnostic test for hidden
hearing loss based on the dynamic range of masking as revealed by auditory evoked potentials.
Building on preliminary results showing 100% transfection efficiency of inner hair cells following
cochlear injection of a designer adeno-associated virus, Aim 2 uses virally mediated
neurotrophin overexpression to extend the trauma-treatment interval over which synaptopathy
can be rescued in the adult ear, beyond the success we have already shown at 24 hrs post
exposure. In Aim 3, we return to neurophysiology and intracellular labeling to ask whether
regenerated ANFs from Aim 2 recapitulate normal ANF response properties, especially with
respect to the robustness of stimulus coding in noise. Lastly, Aim 4 uses a novel behavioral
assay for tinnitus to ask whether synaptopathy per se is necessary for the generation of tinnitus,
and whether the synaptopathy repair achieved in Aim 2 can also reduce or eliminate the tinnitus
percept in animals.

Public health relevance
Project Narrative - Public Health Relevance “Hidden hearing loss” is the permanent damage to nerve fibers connecting the sensory cells of the inner ear to the brain, which occurs in noise-induced and age-related hearing loss well before changes in the threshold audiogram. This nerve damage is likely a major contributor to difficulties understanding speech in a noisy environment that characterize many types of sensorineural hearing impairment and may also be a key elicitor of tinnitus. The research proposed here will directly address how the signal-carrying capacity of the auditory nerve is compromised in hidden hearing loss, how the condition can be diagnosed non-invasively and whether the underlying nerve damage predisposes the subject to the development of tinnitus. The proposed research will also extend our work on the development of therapies for this type of neural damage. The ultimate success of these therapies holds promise to improve the hearing abilities of millions of people with sensorineural hearing loss and to eliminate the suffering that tinnitus produces.